PROTEIN/PROTEIN INTERACTIONS ON HSV DNA POLYMERASE

In the proposed studies, the physical interaction that occurs between the catalytic subunit of HSV polymerase and its processivity factor UL42 will be characterized in detail. A sequence encoding a peptide corresponding to the C-terminal 36 residues of polymerase, which mediate UL42 binding, will be mutagenized and the ability of mutants to bind UL42 will be quantified using a yeast or bacterial two-hybrid system. The helicity Of these peptides and their ability to inhibit processivity will be examined. These studies will characterize the role of the helix-loop-helix structure formed by the C-terminal 36 residues of polymerase in UL42 binding. The region of UL42 between residues 160 and 190 will also be mutagenized and tested for binding activity in a two- hybrid system. The ability of UL42 mutants to stimulate processivity will be determined. These studies will indicate if the polymerase binding site lies within a contiguous region of UL42. The information gained from these studies will be used in the rational design of compounds that inhibit polymerase/UL42 binding. A combinatorial approach to drug discovery will also be taken by using phage display to identify binding inhibitors.